Cardiovascular Epidemiology Training Grant

ABSTRACT This competing continuation application builds on nine successful five-year cycles of NRSA/NHLBI supported academic and applied research training in cardiovascular (CV) epidemiology at the Department of Epidemiology, University of North Carolina (UNC), Gillings School of Global Public Health. The program's goal is to train effective and independent researchers in the disciplines and methods needed to conduct research in CV health, in order to channel qualified scientists into the workforce capable of having a positive impact on the burden of cardiovascular disease. Historical strengths of the program include excellence in research methods training, mentoring, trainee productivity, successful transitions to careers in science, opportunities for experiential learning and career development. This program has actively pursued strategic innovation and ongoing improvements to better prepare population scientists and keep our program salient and effective. New elements to the be added in this continuation application include an external Distinguished Alumni Council and expanded training and research opportunities in data and information science as an additional area of research emphasis. Of the 43 pre-doctoral and post-doctoral trainees completing their degree program or postdoctoral fellowships over the past 15 years, 27 (63%) currently hold faculty positions at major research universities. Overall, 40 (93%) of trainees over the last 15 years currently hold research positions in either academics, federal government, or private industry. The 15 trainees in the program during this cycle published 72 peer reviewed manuscripts, nearly half (49%) of which as first authors. The program's leadership and support structure include a program steering committee, an external advisory body of Distinguished Alumni, and trainee support teams. Distinctive features of the program are effective mentorship, career development planning, modular curriculum structure, on-going peer-led workshops, interdisciplinary seminar series, faculty and trainee-led journal clubs, pragmatic research, and breadth of research collaboration opportunities. The program enjoys strong institutional support. The program also conducts careful evaluation by the trainees and faculty of the effectiveness of the program and its productivity. As part of this application, we request funding for five predoctoral and three postdoctoral trainee positions.

Public health relevance
Project Narrative By continuing to innovate in active learning, engaged mentoring, dynamic research areas, and ongoing self-assessment the Cardiovascular (CV) Epidemiology Training Program at the University of North Carolina seeks to train effective and independent researchers in the disciplines and methods intersecting CV epidemiology. The proposed plan builds on historical strengths of the program and introduces new initiatives to strengthen the training experience. The program's trainees and alumni are exceptionally productive and successful researchers and scholars making important contributions to the field.